Acquisition of a CombiFlash EZ Prep Chromatography System with Integrated ELSD for Chemical Synthesis

PROJECT SUMMARY
Acquisition of a CombiFlash EZ Prep Chromatography System with Integrated ELSD for Chemical
Synthesis
The goals of the continuing R35GM118173 research program “Chemical Synthesis of Complex Natural
Products for Translational Science” involve chemical syntheses of bioactive molecules for translational studies.
An instrument supplement is requested to purchase a Teledyne ISCO Combiflash EZ Prep Chromatography
System with Integrated Evaporative Light Scattering Detector (ELSD) to establish a highly flexible and
complete solution for both normal and reverse-phase purifications of biologically active natural products and
analogues as well as synthetic intermediates in the Porco laboratory at Boston University. The instrument
would replace a dysfunctional prep-HPLC system to enable and expedite research in many ways, as
compound purification is a substantial aspect of the research workflow. Automated solvent fraction collection
would also provide a significant advantage by expediting purifications and enabling increased multitasking and
greater focus on synthetic chemistry. As part of Boston University’s Institutional Support, the Provost Office
has committed to the cost of a service contract from Teledyne Isco to support the chromatography system.

Public health relevance
PROJECT NARRATIVE Acquisition of a CombiFlash EZ Prep Chromatography System with Integrated ELSD for Chemical Synthesis The R35 research program “Chemical Synthesis of Complex Natural Products for Translational Science” R35GM118173 involves chemical syntheses of bioactive molecules for translational studies. An instrument supplement is requested to purchase a preparative HPLC system to establish a highly flexible platform for preparative compound purification and chromatography in the Porco laboratory. The system’s multifaceted separation capabilities will allow for efficient purification of complex synthetic intermediates, natural products, and derivatives in day-to-day research towards the R35 aims to develop pharmacological therapies for human cancers and viral, fungal, and bacterial illnesses. .